Development and application of new tools to identify repeat expansions in human diseases

Frontotemporal dementia (FTD) is a devastating neurological disease that is
characterized by behavioral and personality changes, as well as memory loss as the disease
progresses. In familial FTD, the major genetic cause is a tandem repeat (TR) expansion in
C9orf72, demonstrating that TR expansions can lead to Alzheimer’s Disease Related Dementia
(ADRD). Despite the importance of TRs to FTD, the frequency and function of TR variants
associated with Alzheimer’s Disease (AD) is unknown.
We hypothesize that variations in TR DNA sequences are associated with AD. We have
recently deployed new tools to genotype hundreds of thousands of TRs in the human genome
with high accuracy and precision. Therefore, our overall objective is to identify TR variations
from whole-genome sequencing data in AD and control cohorts. This supplement award will
provide a new angle to analyze thousands of NIH-funded, publicly-available AD datasets
released through the National Institute on Aging Genetics of Alzheimer’s Disease (NIAGADS)
Data Sharing Service. Furthermore, annotating TR variants associated with AD will determine
whether some of these genetic variants are functionally implicated in disease. These results will
illuminate our understanding of genetic risk factors in AD and set the stage for a new class of
precision-targeted therapeutics.

Public health relevance
The proposed research is relevant to public health because it will enable the identification of genetic variants associated with Alzheimer’s Disease, which could serve as the basis for new therapeutics. The proposed research is relevant to NIA because new therapeutic targets are urgently needed for Alzheimer’s Disease.